NCBI: SCIENTIFIC DATA ANALYSIS, ANNOTATION, AND QUALITY ASSURANCE SUPPORT FOR ANTIMICROBIAL RESISTANCE SEQUENCING EFFORTS

To support sequencing of high-priority drug resistant strains for the National Database of Resistant Pathogens.